Investigating functional changes to the visual word form system in post-stroke alexia

Project Summary/Abstract
Reading is vital to life in modern society. Loss of reading ability due to stroke, or alexia, affects approximately
1.3 million Americans and recovery is often incomplete. Reading relies on an area of the brain’s object
recognition system that becomes specialized for word recognition as we learn to read, called the visual word for
area (VWFA). Because reading is a learned skill, it relies on input from the VWFA into brain networks evolved
for more general speech and language processing. There is some evidence that the VWFA also receives top-
down information from language regions, but the importance of this feedback for reading is poorly understood.
Most cases of alexia are caused by strokes to the language network, not the VWFA, raising the question of
whether reading deficits in alexia relate to aberrant VWFA processing caused by disrupted feedback from the
language network. Here, I propose to investigate the hypothesis that damage to the language network causes
dysfunction and triggers plastic changes in visual word processing areas undamaged by the stroke, and that
these changes correspond with reading deficits after stroke.
Further, the brain basis of alexia recovery is poorly understood. Previous studies have shown that both
spared left hemisphere (LH) language regions and their right hemisphere (RH) homotopes contribute to aphasia
recovery, but the role of the RH homotope of the VWFA (rVWFA) in alexia recovery has only been tested in a
few case studies, and only with direct damage to the LH VWFA. I hypothesize that the rVWFA is recruited in
some cases of alexia caused by lesions to the language network, and that this recruitment contributes to reading
performance after stroke, particularly for word comprehension.
To test these hypotheses, this prospective study of 40 chronic left hemisphere stroke survivors and 40
demographically matched controls will identify post-stroke functional changes to the canonical left hemisphere
VWFA (lVWFA) and the rVWFA (Aim 1), determine the relationship of VWFA activity to lesion locations and
disconnections (Aim 2) and examine how this activity relates to reading deficits after stroke (Aim 3). Aim 1 will
employ a novel fMRI VWFA localizer I designed to characterize activity in the lVWFA and rVWFA. Aim 2 will
conduct voxelwise and structural connectome-based multivariate lesion-symptom mapping analyses to elucidate
brain regions and disconnects related to atypical VWFA activity. Aim 3 will employ a hierarchical regression
approach to determine the relationship of VWFA activity to deficits in oral word reading, silent word recognition,
and silent word comprehension. The proposed research will advance our understanding of the interplay between
language regions and visual word processing areas, and of the brain basis of alexia and alexia recovery. By
completing this project and the associated training plan, I will learn to conduct fMRI and behavioral research in
people with alexia and aphasia, which is key to my ultimate goal of developing into an independent investigator
studying mechanisms of neural plasticity in higher cognitive functions after injury.

Public health relevance
Project Narrative Post-stroke alexia, an acquired reading disorder affecting approximately 1.3 million Americans, causes a great deal of suffering and recovery is limited. The proposed research seeks to elucidate the neural mechanisms underlying post-stroke alexia by investigating functional changes in the visual word form system following damage to the language network. By investigating the relationship between atypical brain activity patterns, lesion characteristics, and behavioral deficits, this study will enhance our understanding of neural plasticity in alexia recovery and offer insights to inform targeted interventions for stroke survivors.